Core B (Metabolomics Component)

Core B (Metabolomics Component) -­ Project Summary

The metabolomics core will support this Program Project application by providing infrastructure, expertise and
support in metabolomics to investigators of the Program Project. The core will provide expertise in measurement
of steady state levels of metabolites and their flux in cell lines and in tissue extracts isolated from a variety of
genetically engineered mouse models. The metabolomics core will also provide assistance with downstream
data analysis and interpretation in the context of pathways, as well as support the development and
implementation of innovative methods to integrate OMICs-­based datasets.

Public health relevance
Core B (Metabolomics Component) - Project Narrative The metabolomics core will support the investigators of this Program Project by providing support for the analysis of small molecules or metabolites using advanced detection methods employing mass spectrometry. Both steady state levels of metabolites, as well as activity of metabolic pathways will be measured. The core will also support associated data analysis and interpretation through cooperation with the Bioinformatics/Statistics component of Core A.